HIV-1 vaccine design emphasizing bnAb targets on membrane Env liposomes

Project Summary
A vaccine that elicits broadly neutralizing antibodies (bnAb) could protect against HIV/AIDS. All bnAbs
must act on the membrane embedded form of the HIV-1 envelope glycoprotein (m-Env), however typical
vaccines use soluble, truncated forms of Env as an imperfect surrogate that is simpler to formulate. We have
been developing a m-Env vaccine strategy that presents purified m-Env in multivalent form on liposomes,
which we term, m-Env liposomes (MELs). MELs have been enabled in part by development of stable, well-
ordered m-Env and producer cells that generate them in high yield. Preliminary Studies show that
heterologous MEL immunization elicited sporadic tier 2 cross neutralizing antibody responses.
Immunogenicity of the transmembrane Env subunit, gp41, is underexplored in the membrane context. With
MELs, immunogenicity of m-Env gp41 can now be studied with molecular precision, and without the
neoepitopes associated with soluble Env. In SA1, we will immunize rabbits using MELs to determine how
neutralizing antibody responses are affected by gp41 immunofocusing strategies, including the creation of
gp41 `glycan holes', boosting with multivalent epitope-specific immunogens based on membrane-proximal
external region (MPER) and fusion peptide, and by boosting sequentially with heterologous Envs. Later,
human Ig locus knockin (KI) mice will be immunized with m-Envs, including those that bind tightly to an
inferred germline precursor (iGL) of a novel bnAb that we show has capacity to directly bind to the MPER
and neutralize HIV-1. In SA2, we will isolate MPER/gp41 bnAbs from Chinese donors samples using B cell
sorting and next generation sequencing bioinformatics techniques. We will also interrogate the gp41-
specific B cell response in MEL immunized hu Ig KI mice to determine whether MPER bnAb-like iGLs
expanded. In SA3, we will screen Envs from donors in part on the basis of affinity for MPER bnAb and
cognate precursors to understand the mechanism of binding, and to generate novel immunogens. Overall,
we aim to understand how to elicit bnAbs to gp41 that recognize a well guarded, but nevertheless
vulnerable surface at the base of the HIV-1 Env spike.

Public health relevance
Project Narrative To develop an improved HIV vaccine, we will focus on a vulnerability on the HIV spike close to the viral membrane. We will make strategic changes to this target on our vaccines, and see if the changes combine to produce antibody responses in small animals that block HIV-1 from infecting host cells.